Interrogating NFKBID dependent humoral immunity to Toxoplasma gondii

PROJECT SUMMARY
Immunological memory is the ability of our immune system to respond with greater strength and quickness
upon re-encounter with the same pathogen (i.e. secondary infection). Immunological memory is the basis for
vaccination which remains the most successful method for preventing infectious disease. Yet, a fully protective
vaccine that prevents a single human parasitic disease has not been realized to date. Why is immunity to
parasitic pathogens so difficulty to achieve? Our current work on secondary infections with the
apicomplexan parasite, Toxoplasma gondii, suggests that protective immunity is genetically determined. In this
grant submission, we highlight a published forward genetic approach using an AxB,BxA mouse panel that
revealed the transcriptional regulator of NF-κB, IκBNS, encoded by Nfkbid, is required for humoral immunity to
T. gondii. However, the mechanism by which IκBNS mediates protective immunity against T. gondii is not fully
understood. We hypothesize that IκBNS determines the protective capacity of CD4 T follicular helper
(Tfh) responses to Toxoplasma gondii. Experimental approaches from immunology and molecular biology
will be utilized to test these hypotheses. In Aim 1, a series of mouse lines with cell-specific deletions of Nfkbid
will be used to understand the nature of the humoral defect in Nfkbid null animals. We hypothesize that Nfkbid-
deficient Tfh cells are unable to help B cells mount antibody responses to T. gondii. We propose to define the
transcriptional regulation mediated by IκBNS, including its impact on NF-κB-gene interactions, that confers
enhanced Tfh responses and immunity to T. gondii. In Aim 2, we will explore how T and B cell intrinsic
expression of Nfkbid influences immunity to virulent challenge with T. gondii, and the role of IκBNS-dependent
antibodies in mediating this protection. With the overarching goal of preventing human toxoplasmosis, insights
gained from this R21 proposal will guide future projects on vaccine and therapeutic strategies that best prevent
toxoplasmosis in susceptible mice.

Public health relevance
PROJECT NARRATIVE Parasitic disease inflicts great morbidity worldwide, yet there is only one partially protective vaccine currently in use for malaria prevention. In this proposal, we will leverage results from a large-scale forward genetic screen designed to identify requirements for immunity to the widespread parasite of mammals, Toxoplasma gondii. Specifically, an understudied transcriptional regulator was identified, and we will interrogate the mechanism by which this regulator promotes protective antibody responses to parasitic infection.